Translational Immunology Training Program

Project Summary/Abstract
This is a revised, competitive renewal, T32 application in which we have coalesced and reconfigured two
previously distinct and successful T32 programs at the Icahn School of Medicine at Mount Sinai (ISMMS), a
post-doc program in Transplant Immunology [(P Heeger, former program director (PD)] and a pre-/post-doc
program in Immunology (S Lira, former PD), into an expanded pre- and post-doctoral training program in
Translational Immunology (P Heeger and S Lira Co-PDs). Combining the programs will a) enhance
translational immunology training (including training in transplantation) through cross fertilization (e.g. exposing
trainees in cancer immunology to transplant immunology, immunodeficiency and autoimmunity through a joint
training venue) b) leverage common training faculty and institutional resources, as well as a revised
immunology-focused, administrative infrastructure (including education, career development and evaluation
processes) to enhance function and efficiency of the training experience, and c) limit overlap among training
faculty. Additional rationale include 1) our success over the past 16 years in attracting and training pre- and
post-doctoral MD, PhD and MD/PhD trainees into immunology research careers, 2) the continued need for
improving outcomes of immune-mediated diseases 3) our desire to positively impact the education of future
basic and translational investigators in immunology, and 4) the fact that our training environment and research
foci are well-suited to offer diverse basic and translational immunology research opportunities for trainees. The
exceptional ability of Mount Sinai's immunology community to make fundamental discoveries, to translate the
results into novel and effective diagnostic and therapeutic strategies, and to incorporate pre- and post-doc
training into its research mission underscores the significance of this revised training program. The overall
objective of this program is to attract and train talented MD/PhD and PhD students and post-docs over 2 year
periods, for successful, independent careers in immunology relevant to human disease. We have a diverse,
well-funded faculty with broad interest in immunology and a strong pool of pre- and post-doc trainees that
includes significant numbers of underrepresented minorities. The program is designed to provide training by
individual mentors performing research in all aspects of Immunology relevant to human disease. The program
is supported with strong oversight and administrative structure, significant didactic training in Immunology,
scientific writing and career development, and contains newly added state of the art evaluation approaches
with defined goals and benchmarks for success so as to optimize the development of independent academic
researchers in the field.

Public health relevance
Project Narrative This revised pre- and post-doctoral training program in Translational Immunology will attract pre-doctoral PhD and MD/PhD as well as post-doctoal MD, PhD and MD/PhD candidates into a comprehensive training environment to teach them cutting edge Immunology relevant to human disease so as move the field of translational immunology forward. The program is directly relevant to public health in that its goal is to train the next generation of leaders in Immunology and thus be able to improve outcomes of patients with cancer, autoimmune disease, allergies, immunodeficiencies, transplanted organs, among others.